XENOPUS OOCYTE NUCLEAR ENVELOPE STRUCTURE

This research continues the development of methods for simultaneous preservation of the lamin network, nuclear pore complexes, and the intranuclear pore connecting cable system. In recent studies, I have developed a nuclear isolation buffer that prevents the swelling of the nucleus, which leads to stretching and disruption of the lamin net and the pre connecting cables.